VEDS Year2-Continuation of the Nonalcoholic Steatohepatitis Clinical Research Network (NASH CRN) Data Coordinating Center

Project Summary/Abstract
Nonalcoholic fatty liver disease (NAFLD) affects one in three adults and one in five children in North
America and is a growing public health issue in the United States and many parts of the world. NAFLD, and
especially nonalcoholic steatohepatitis (NASH), may lead to cirrhosis requiring liver transplant, and liver
cancer, as well as liver-, cardiovascular-, and cancer-related morbidity and mortality, resulting in increased
health burdens and associated costs. The Nonalcoholic Steatohepatitis Clinical Research Network (NASH
CRN) has been sponsored by the National Institutes of Health (NIH) since 2002 and has provided important
information regarding the natural history and treatment of NAFLD and NASH in adults and children, and has
set the stage for translational research focused on the pathogenesis, diagnosis, treatment, and clinical
management of these patients. This supplement application is in response to the Administrative Supplements
to Existing NIH Grants and Cooperative Agreements (PA-20-272) as part of our parent award Limited
Competition for the Continuation of the Nonalcoholic Steatohepatitis Clinical Research Network (NASH CRN)
Data Coordinating Center (DCC). The DCC aims for the continuation in response to the PA are: 1) To initiate
and complete the Vitamin E dosing study (VEDS) treatment trial and 2) To provide the DCC functions
necessary to complete VEDS including: research leadership, financial management and disbursement of
per capita payments to the VEDS clinical centers, expertise in biostatistical analysis, data management,
multicenter coordination, quality control methods, safety oversight, project support, communication, and
organization. The DCC has worked productively with the clinical centers in the past and is eager to continue
its collaboration with the clinical centers as well as with NIDDK program staff, to complete these important
research objectives.

Public health relevance
Project Narrative Nonalcoholic fatty liver disease, and especially NASH, are a leading cause of chronic liver disease in both adults and children, and are associated with increased liver-related morbidity and mortality. The NASH CRN aims to transform innovative scientific discoveries from clinical and translational research to better understand the natural history of the disease, develop a better means of diagnosis and treatment, understand the pathogensis, and reduce the incidence and burden of adverse outcomes due to NAFLD and NASH. The VEDS trial will determine the minimum effective dose of Vitamin E in treating NAFLD.